Rochester Network Lead Academic Participating Site

PROJECT SUMMARY/ABSTRACT
The University of Rochester, Wilmot Cancer Institute is a health and research institute ideally suited to achieve
the goals of the NCI NCTN as a Lead Academic Site to improve the lives of people with cancer. Our longstanding
activity as U10-funded members of ECOG (1968-2002) and SWOG (2002-2012) as well as our dedication to
NCTN trials over the past 5 years indicate our continued investment in and commitment to clinical and
translational laboratory research in cancer, particularly the development of and accrual to late-phase Cancer
Clinical Trials. In an era where both the biology of cancer and development of novel therapeutic strategies have
become more complex, requiring multidisciplinary teams of investigators and extensive tissue banking and
correlative studies, our translational scientific program and dedication to the NCTN program is critical for ultimate
success.

Public health relevance
PROJECT NARRATIVE (Award Period 03/01/2023-02/29/2024) The University of Rochester and Wilmot Cancer Institute has a long-standing history of conducting clinical research through the NCI’s National Clinical Trials Network. Our commitment to clinical trials and the impact they have on clinical care is evidenced by our increasing accrual rates leading to recognition as a High Performance Site and expanded involvement of Wilmot investigators within the NCTN. This award will continue to support our research activities, develop impactful clinical trials, mentor the new researchers, and provide cutting edge treatment options for patients.